Mechanisms and regulation of replication, the cell cycle, gene expression, and horizontal gene transfer in prokaryotes, focusing on Bacillus subtilis.

Project Summary/Abstract
Horizontal gene transfer (HGT) is a driving force in microbial evolution. It is largely mediated by mobile genetic
elements, including viruses, conjugative plasmids, and integrative and conjugative elements (ICEs; aka conjugative
transposons), and many bacterial genomes contain several mobile genetic elements, including ICEs and temperate phages.
Conjugative elements are well known agents that contribute to the spread of genes for antibiotic resistances, virulence,
symbiosis, metabolic functions, and more. ICEs were first discovered because they confer some of these phenotypes.
However, potential phenotypes conferred to bacteria by the vast majority of ICEs are not known. Our recent work
indicates that ICEs confer beneficial phenotypes that extend well beyond those of some of the previously characterized
ICEs, and that some of these phenotypes involve functional interactions between ICEs and bacterial viruses.
We are focusing on mechanisms controlling horizontal gene transfer, interactions between mobile genetic elements
and their host cells, and the interplay between different mobile elements found in the same cell. Many of our studies are
initiated in the bacterium Bacillus subtilis. It is easy to grow and manipulate, naturally contains a variety of mobile
elements, including one ICE (ICEBs1) and one functional (SPß) and two defective (PBSX, skin) temperate phages,
together comprising almost 6% of the genome. Our recent work indicates that there are beneficial phenotypes conferred
by ICEBs1 to host cells that extend well beyond those conferred by previously characterized ICEs, including effects on
the timing of sporulation and the activity of other resident elements.
Despite the prevalence and importance of ICEs, there are major deficiencies in our understanding of these elements,
especially in Gram positive bacteria. Notably, little is known about the interactions between ICEs and their host cells
including with co-resident viruses, and the effects ICEs have on fitness of their bacterial hosts. Furthermore, little is
known about the interactions between functions encoded by ICEs and those encoded by hosts, and how these interactions
influence and determine the host range and efficiencies with which ICEs function in different species. Our work will
continue to focus on the lifecycle of ICEBs1 and Tn916, an ICE that is naturally found in several bacterial pathogens and
is involved in the spread of tetracycline resistance between them. The ability to experimentally induce ICEBs1 in ~25-
90% of cells in a population, to achieve relatively high conjugation frequencies, and to visualize events in single cells has
allowed us to answer previously difficult or unstudied problems fundamental to the ICE lifecycle. Our expertise in
chromosome dynamics, DNA replication, stress responses, and microbial development dovetails nicely with our studies of
ICEs and phages, notably how these processes affect the lifecycles of mobile genetic elements and how mobile genetic
elements affect these processes. We plan to pursue these interests, with particular focus on the connections between ICEs,
phages, and cellular processes. Our findings should be relevant to the biology of many bacterial species, especially
regarding the transfer of genes between bacteria growing in different environments, including the human microbiome.

Public health relevance
Project Narrative This work investigates several fundamental and conserved processes used by bacteria for the acquisition of new genes and traits via horizontal gene transfer, for responses to cellular stresses, and for growth and propagation. Our focuses on the mechanisms controlling conjugation (a prevalent type of horizontal gene transfer) and the interplay between conjugative elements and bacterial viruses (bacteriophage), and between mobile genetic elements and their host cells. This work is directly related to mechanisms of bacterial survival, horizontal gene transfer, and competition between selfish DNA elements.